Admin Core

Abstract
The Administrative Core (Core A) will provide support for all administrative and fiscal duties pertaining to the
Program Grant. Core A will coordinate meetings including monthly PPG meetings, annual retreats and
conference calls, and will handle all PPG-related correspondence, document preparation, and submission of
collaborative manuscripts. The Administrative Core will also assist with noncompeting and competing renewals,
will maintain a secure file server for data sharing for the project leaders to easily access and share data among
the three institutions, and provide assistance with biostatistics and Webex conferencing. The fiscal duties that
will be supported by the Core will include maintaining and reconciling accounts, budget preparation, and
subcontract management.